Epitranscriptomic regulation by m6A RNA methylation after stroke

Many functional groups attach covalently to RNAs to enhance the functionality of the cellular transcriptome.
Particularly, the methyl group modification N6-methyladenosine (m6A) is regarded as the fifth nucleobase in the
adult brain. With its diverse and context-specific roles in mRNA processing, m6A is implicated in the progression
of acute CNS injuries and chronic neurodegenerative diseases.
As the role of m6A in post-stroke brain is not yet evaluated, we will test the hypothesis “m6A hypermethylation
is a major modulator of post-ischemic brain damage.”
Preliminary studies showed that transient focal ischemia significantly increases the m6A methylation in adult
mouse brain. We also observed that the m6A writer complex is unaltered, but the brain-enriched m6A eraser FTO
was down-regulated in the post-stroke brain. Preliminary studies showed that treatment with an FTO AAV9
vector increased cerebral FTO expression and prevented m6A hypermethylation in the post-stroke brain. This
indicates that FTO downregulation, rather than increased methylation, is responsible for the observed sustained
m6A-hypermethylation after stroke. FTO AAV9 also decreased secondary brain damage, and improved motor
and cognitive functional recovery in mice of both sexes subjected to focal ischemia. We further observed that
post-stroke treatment with NADPH activates FTO and demethylates m6A-tagged RNAs. NADPH also protected
post-stroke brain. Based on this, Aim 1 will evaluate if post-stroke brain can be protected by inducing FTO with
NADPH following many STAIR criteria.
Of all the 122 RNAs hypermethylated by >5-fold in the ischemic brain, c-Jun RNA harbors the highest number
of 19 bonafide m6A motifs. c-Jun is a mediator of apoptotic gene expression, and FTO overexpression
demethylated c-Jun mRNA and prevented its translation in the post-stroke brain. Based on this, Aim 2 will test
if c-Jun hyper-m6A methylation mediates post-stroke apoptosis and the ensuing brain damage.
Binding of m6A reader YTHDF1 promotes translation of m6A-tagged transcripts. Preliminary data showed
induction of YTHDF1 expression and increased binding of m6A-methylated c-Jun to YTHDF1 following focal
ischemia. We further observed that FTO overexpression decreased the abundance of m6A-methylated c-Jun
and reduced its binding to YTHDF1. YTHDF1-/- mice didn’t show induction of c-Jun protein expression after
ischemia. This indicates that both increased m6A methylation and YTHDF1 binding are essential for translation
of c-Jun. Based on this, Aim 3 will test if m6A reader YTHDF1 plays a role in post-ischemic brain damage.
The overall goal is to understand the mechanisms and therapeutic potential of m6A methylation after stroke.

Public health relevance
Role of post-transcriptional RNA modifications (epitranscriptomics) in promoting ischemic brain damage is not yet evaluated. The present project will study the significance of the methylation of adenine in RNAs (m6A) that is observed to be altered after stroke in rodents. We will test the efficacy of NADPH treatment which decreases the abundance of m6A-modified RNAs as a putative therapy to protect brain after stroke.